Remotely Observed Methadone Evaluation (ROME)

1. Executive Summary of Sonara Health SBIR Phase I and Team
Methadone is an effective treatment for patients with opioid use disorder (OUD), however its use
is highly regulated at the federal and state level due to concerns of overdose and diversion. As a
result, methadone can only be administered in OTPs, and it can take patients months of care
before an OTP will authorize take-home methadone. These barriers can reduce patient
engagement and retention, which severely impacts health outcomes. They can also prevent OTPs
from fully being able to serve their communities.
Sonara is an innovative solution that reduces friction for OTPs providing life-saving methadone
treatment for opioid use disorder. It works by combining a secure web platform with low-cost,
tamper-evident, single-use packaging to track per-patient, per-dose adherence to take home
methadone. Clinicians have the ability to view each dosing session on-demand (i.e.
asynchronously) to ensure patient adherence to treatment regimens and intervene in the case of
concerning patient behavior.
Through Sonara's remote observation platform, clinicians are able to increase access to
take-home methadone, while preventing opportunities for diversion or misuse. It will also
improve accountability and transparency for patients and providers alike by actively reporting
key indicators of recovery success. These goals serve to advance patient engagement and
retention, which in turn improves clinician engagement, and ultimately the health outcomes of
patients.
The objective of Sonara Health's SBIR Phase I grant awarded and initiated in October 2022 was
to conduct feasibility testing of the minimum viable product (MVP of Sonara's web application
and evaluate its performance for opioid treatment programs (OTPs) in dispensing take-home
methadone in a safe and responsible way.
The specific aims of the proposed study are:
1) Conduct feasibility testing of Sonara's minimum viable product with patient- and
clinician-facing web application and evaluate tracking performance
2) Research, develop, and integrate a measurement-based care framework that measures
frequent, personalized improvement to a patient's OUD outcomes and delivers them to
their care team
3) Assess the demand and acceptability of Sonara among providers and target patients
The proposed I-Corps team will include the following three members.
Member Name Role
Justin Geller Industry Expert
Michael Giles, M.D. C-Level Corporate Officer (CEO)
Kim Hoffman, PhD PD/PI
All three members are committed to the time required by the I-Corps program.

Public health relevance
1. Executive Summary of Sonara Health SBIR Phase I and Team Methadone is an effective treatment for patients with opioid use disorder (OUD), however its use is highly regulated at the federal and state level due to concerns of overdose and diversion. As a result, methadone can only be administered in OTPs, and it can take patients months of care before an OTP will authorize take-home methadone. These barriers can reduce patient engagement and retention, which severely impacts health outcomes. They can also prevent OTPs from fully being able to serve their communities. Sonara is an innovative solution that reduces friction for OTPs providing life-saving methadone treatment for opioid use disorder. It works by combining a secure web platform with low-cost, tamper-evident, single-use packaging to track per-patient, per-dose adherence to take home methadone. Clinicians have the ability to view each dosing session on-demand (i.e. asynchronously) to ensure patient adherence to treatment regimens and intervene in the case of concerning patient behavior. Through Sonara’s remote observation platform, clinicians are able to increase access to take-home methadone, while preventing opportunities for diversion or misuse. It will also improve accountability and transparency for patients and providers alike by actively reporting key indicators of recovery success. These goals serve to advance patient engagement and retention, which in turn improves clinician engagement, and ultimately the health outcomes of patients. The objective of Sonara Health’s SBIR Phase I grant awarded and initiated in October 2022 was to conduct feasibility testing of the minimum viable product (MVP of Sonara’s web application and evaluate its performance for opioid treatment programs (OTPs) in dispensing take-home methadone in a safe and responsible way. The specific aims of the proposed study are: 1) Conduct feasibility testing of Sonara’s minimum viable product with patient- and clinician-facing web application and evaluate tracking performance 2) Research, develop, and integrate a measurement-based care framework that measures frequent, personalized improvement to a patient’s OUD outcomes and delivers them to their care team 3) Assess the demand and acceptability of Sonara among providers and target patients The proposed I-Corps team will include the following three members. Member Name Role Justin Geller Industry Expert Michael Giles, M.D. C-Level Corporate Officer (CEO) Kim Hoffman, PhD PD/PI All three members are committed to the time required by the I-Corps program. 2. I-Corps Team & Project Plan Phase I was successfully initiated in Fall 2022 with Aim 1 completed and showing promising results. Sonara is currently working with its partners to complete Aim 2 and 3 within the timeline of the Phase I grant. Sonara is also preparing to transition to Phase II, where research will expand to test Sonara’s influence on retention in care and access to take-homes, assess the influence on patient and payer costs of care, and explore the change in health-related quality of life among patients with and without Sonara. Successful implementation of the proposed research has the potential to create a new care paradigm in the methadone treatment space where patients are on an achievable roadmap to increased access to take-homes and recovery, and providers are able to safely and responsibly dispense take-homes. Our proposed I-Corps team will include the following three members: Member Name Role Justin Geller Industry Expert Michael Giles, M.D. C-Level Corporate Officer (CEO) Kim Hoffman, PhD PD/PI The team meets all the core requirements of the I-Corps program and has previously demonstrated and continues to show a strong commitment to innovation, commercialization, and entrepreneurship. The team has already been working on conducting acceptability and feasibility testing (one of the aims of Phase I), and the commercialization of Sonara’s product, and thus is the best equipped to continue their efforts under the I-Corps program. Mr. Geller is an experienced founder with extensive experience in the healthcare and consumer services industry. Mr. Geller has successfully founded three technology companies and guided them from seed to profitability. Mr. Geller is uniquely qualified for the commercialization of Sonara, as his previous startup, Monument, was an online treatment program for people with alcohol use disorder. Dr. Giles is the founder and CEO of Sonara Health. Dr. Giles has been personally involved with business and product development as well as leading Sonara’s investment rounds. Given Dr. Giles’s strong stake in the success of the company and his extensive experience interviewing and meeting with industry leaders, he is well suited to fully utilize the I-Corps program. Dr. Hoffman is a Senior Researcher at the Oregon Health and Science University, where she brings over 20 years of experience conducting rigorous academic research and program evaluation. She was closely involved with Sonara’s successful Phase I grant and conducted the qualitative interviews with patients and providers. Her interviewing expertise would be invaluable to the I-Corps team and would help Sonara maximize the program’s full potential. Since the beginning of the Phase I grant, Mr. Geller, Dr. Hoffman, and Dr. Giles have frequently collaborated on initiatives to further innovate Sonara’s product, develop new industry relationships, and commercialization plans. Therefore, keeping the same team together for I-Corps reduces any friction onboarding a new member would have, and instead builds on the existing relationships the team has. The proposed team can also fully maximize the potential of the I-Corps program as they have a thorough understanding of the product and its current state of development, the target customers, and a strong vision for Sonara’s continued success. While the team has done comprehensive assessment into the marketplace Sonara is entering, key audiences, and profit models, they also look forward to the new knowledge and insight that can be attained through I-Corps. Via exhaustive vetting from I-Corps interviewees, such as potential customers and industry thought leaders, the I-Corps team can attune their product development and business plans to ensure Sonara’s future achievements. As outlined and evidenced above, all three members have a personal and mutual stake in the success of Sonara and thus, are fully committed to meeting the time requirements of the I-Corps program. 3. Potential Commercial Impact Commercial Potential There are encouraging factors that create a favorable environment for Sonara’s continued commercial growth. The first and most important one is that the regulatory environment grows more and more advantageous for Sonara. SAMHSA has given states blanket exemptions for stable patients to receive up to 28 days of take-homes and up to 14 days of take-homes for patients who are less stable. Furthermore, in December 2022, SAMHSA proposed new federal rules that permanently and greatly expanded access to take-homes for all patients. The determination of take-home regimens would largely be left up to providers, based on their own risk/benefit analysis. In this new climate, patients will be asking for more take-homes and providers will be looking at how to do so safely. Sonara provides a platform that serves both their needs. Secondly, fentanyl is driving a newer and deadlier phase of the opioid epidemic, and methadone treatment is still the preferred standard of care for opioid use disorder involving fentanyl. With SAMHSA’s proposed expansion, industry experts are predicting a substantial increase in the number of patients receiving methadone, reaching up to 1.2 million patients in 2024, up from just 600,000 in 2022. With renewed focus on the fentanyl and opioid crisis, billions of dollars have been pouring in at the state, local, and federal levels to discover new models and solutions. The OUD market was valued at $2.88 billion in 2021 and is expected to grow up to $5.64 billion by 2029. Sonara is well positioned to take advantage of this influx with its digital-oriented methadone treatment model. The I-Corps team plans to use the program to pinpoint how best to take advantage of this inflow of new funding, and integrate it into Sonara’s commercialization plan. Target Customer Sonara has three target customers in mind: opioid use disorder patients, payers (this includes private insurance and government programs like Medicaid), and researchers performing clinical trials. Methadone maintenance is a long-term treatment program for opioid use disorder. Under current regulations, patients must visit the treatment center daily during their first 90 days of treatment to receive their dose. These strict attendance requirements can interfere with a patient’s day-to-day responsibilities and is often cited as the primary reason for dropping out of treatment. Once patients pass this initial gauntlet, the recommended time in treatment can range from one to up to twenty years in treatment. Access to treatment centers is also cited as a large barrier preventing patients from seeking treatment; 71% of rural counties don’t have an opioid treatment program. Sonara’s remote dosing observation technology can alleviate many of the impediments that patients face. The proposed I-Corps team would plan to conduct end user interviews with patients so that Sonara could continue making usability improvements. For payers, medication adherence is a key component of cost savings and measurement-based care. On average, adherent patients cost healthcare plans three to five times less as non-adherence is often a driver of adverse events such as emergency room visits, hospitalizations, and readmittance. Poor adherence is estimated to cost $100 - $290 billion a year in healthcare spending. On the non-medical side, Non Emergency Medical Transport (NEMT) costs state and local governments billions a year. The proposed I-Corps team is extremely motivated to sit down with payers, both private and public to discuss how Sonara can aid in their mission to deliver equitable, high-quality care that is affordable. Finally, a target market that Sonara is looking to tap into are clinical trials on human health outcomes, particularly involving new therapeutics or diagnostic tools. Sonara’s technology can help improve participant diversity by allowing participants who otherwise would not be able to take part in clinical trials due to location or time requirements. Sonara can also improve participant adherence and compliance with trial protocols. Adherence (or the lack thereof) can have significant ramifications on the assessment of the Investigative Medical Product (IMP) and the financial health of the trials. The proposed I-Corps team would conduct interviews with industry experts and companies in this space to examine where the stumbling blocks are in clinical trial adherence and compliance and discuss how Sonara could help. Clinical Need and Current Alternatives Access and adherence to methadone maintenance treatment has been a long standing issue since it was introduced over 50 years ago. It represents a complex mix of social standing, stigma-based lack of trust in institutions, medications, and illness, and behaviors impacted by unmet social needs. Patients are put in the unenviable position of choosing their treatment or their day-to-day lives. Key factors include affordability, transportation, and employment or educational opportunities. The methadone treatment space is primed for new technologies and innovations; the standard of care remains virtually unchanged from what it looked like in 1970 and providers and patients are demanding more be done. Sonara is a novel approach to take-home methadone that aims to make take-home methadone more accessible for patients and safer for providers to dispense. Sonara uses a patented web and mobile application that alerts patients when it’s time for their dose and records them taking it. Sonara combines this digital platform with its patent-pending QR encoded, tamper-aware labels to gather and deliver vital information to clinicians and care teams. Sonara also takes an equity first design approach that’s designed to meet the needs of the patient population being served. It’s designed to work on a variety of smartphones, including the ones provided for free by the Lifeline Program. There are no downloads required and it supports offline recording capability. For treatment centers, it’s an off-the-shelf solution that doesn’t require extensive clinical or IT workflow overhauls to work. The market for alternatives to Sonara is small for the moment. Public health agencies will often employ Directly Observed Therapy (DOT) where a nurse observes the patient taking their medication. While there have been some forays into electronic DOT (eDOT) with companies like eMocha and Ai Cure, the field is very much in its infancy and no eDOT services exists in the methadone maintenance treatment space. Competitive Advantages While Sonara is a newcomer in this space, it has several advantages over its competitors. Most of its competitors are focused more on treatment security to ensure that take-home methadone is not diverted or misused. These solutions involve technologically advanced lockboxes or smart pill dispensers that work via fingerprinting or corneal recognition. Companies in this space include MedicasSafe and Abiogenix. While they may be useful on an individual or case-by-case basis, these solutions are expensive, clunky, and difficult to scale, especially considering the breadth and scope of the opioid crisis in the coming years. On the other hand, Sonara operates a much simpler SaaS model that is low-cost for patients and providers. Its plug-and-play approach requires minimal training and is easy to integrate in both clinical workflows and patient’s daily routines. Providers are also able to gather significantly more information about their patient’s treatment prognosis and quality of life than they would from a smart lockbox. Meanwhile for patients, Sonara’s low barrier to entry and ease of use allows them to focus on doing the things they love to do rather than be bogged down by their treatment. Price Estimate Sonara runs two monetization models. The first is a per user, per month fee that is billed to the treatment center or program administrator. Most payers and treatment centers will be billed under this payment program. The second is a fixed pricing model based on the duration and number of patients. This payment program is geared towards clinical trials where there is a fixed study duration. One of Sonara’s goals through I-Corps is to discover how to better attune our pricing models to best suit customers. 4. Project Plan Sonara already has a fully functioning product, as demonstrated below. It has been successfully implemented in eight treatment centers across the country in partnership with some of the largest OTP groups in the country. The technology that Sonara is based on has also been patented in the United States. Sonara was awarded the SBIR Phase I grant in the Fall of 2022 and immediately set to work with its partners at the Oregon Health and Science University (OHSU) and Adapt Roseburg. The research was successfully completed a month after the award. A manuscript has been written and submitted for review. The results are very promising, pointing to commercial acceptability and feasibility among patients and providers, while also providing constructive feedback about how Sonara can better improve its product offerings. With a successful Phase I complete, Sonara is currently working with its research partners at OHSU on a Phase II application for submission in April of 2023. With the Phase II grant, Sonara would expand its aims outlined in ‘Section 2. I. Corps Team & Project Plan’. With a Phase II grant, participant recruitment would be considerably large and much more clinically rigorous by following a randomized controlled trial protocol, so that Sonara can properly test the effects of the platform developed. Also following the successful completion of Phase I, Sonara is actively pursuing commercialization and is in negotiations with over 10 treatment centers to use Sonara to increase access to take-home methadone. Sonara believes that I-Corps would be tremendously beneficial in understanding the marketplace and how it can best serve patients and providers.